Nanoparticle-Enhanced Radiation Therapy for DIPG

ABSTRACT
Peter Chiarelli, MD DPhil, is a clinician-scientist in the field of pediatric neurosurgery, who is focused on the
application of photochemical techniques to treat disease of the human brain. This K08 mentored career
development award will provide the advanced training and mentorship within the fields of biological sciences,
including design and refinement of tumor models, application/evaluation of biological assays, and practical use
of advanced microscopy for biological systems. Supplementing this critical training gap will provide the
resources for success as an independent investigator in the translational application of novel technologies
grounded in the realm of physical chemistry. RESEARCH CONTEXT: Diffuse intrinsic pontine glioma (DIPG) is
a tumor of the brainstem that occurs in children, with no available option for safe surgical resection, and no
effective current chemotherapeutic strategy. The development of alternative therapies for this incurable brain
cancer is a priority among pediatric neuro-oncology consortia. A new approach for the treatment of DIPG is
proposed, grounded on successful pre-clinical work with a different high-grade brain tumor (murine xenograft
model of supratentorial glioblastoma). This method takes advantage of the radiation which is already
necessary for children with DIPG, and uses targeted ~35 nm biocompatible poly(ethylene glycol)(PEG)-coated
iron oxide core-shell nanoparticles (NPs) to modify the effects of incident radiation by inducing Auger
photoelectron ejection from the nanoparticle core. Through the biochemical targeting of NPs to the tumor cells,
the effect of radiation is spatially enhanced within sub-micron distances from the NP, allowing the possibility of
lower overall radiation doses to be delivered with greater tumor cytotoxicity. This research project will use a
reliable murine model of DIPG, and apply targeted iron oxide-PEG NPs through two different methods:
intravenous (IV) delivery, and convection-enhanced delivery (CED) to the brain. A mechanistic exploration of
the NP-Auger effect will also be carried out using 2-dimensional thin films, to better understand the spatial
extent over which photoelectron ejection exerts a biological effect. The goal of developing this technology is
the translation to human pediatric clinical trials for DIPG, and to achieve the first substantial improvement in
outcome observed over the past 3+ decades. CAREER DEVELOPMENT PLAN: Dr. Chiarelli will complete
coursework on the advanced tumor biology in animal models, methods in benchtop molecular biology, and
quantitative imaging (cell culture and tissue). This coursework will be integrated with the sequence of specific
aims included in this proposal, so that training can be directly applied to the research. An interdisciplinary team
of mentors with expertise spanning clinical neuro-oncology, live-cell imaging, DIPG biology, biomaterials
design, and physical chemistry of 2-D surfaces has been assembled to provide close mentorship for Dr.
Chiarelli, and the guidance necessary for clinical translation of the included work, presentation at professional
meetings, as well as progress towards independent funding (R01 submission).

Public health relevance
Project Narrative DIPG is one of the most lethal pediatric brain cancers, affecting children aged 5-9 yrs old, without a current cure or significant improvement in the efficacy of treatment over the past 3+ decades. With the promise of improving quality of life, improving the safety of radiation, or increasing length of survival for children with DIPG, nanoparticle-enhanced radiation therapy first requires validation in a pre-clinical DIPG model, and additional mechanistic investigation. The included project proposal is focused on the pre-clinical development and refinement of this technique.